Tumor-TAMs crosstalk enables bypass of oncogenic KRAS dependency in pancreatic cancer

Project Summary/Abstract
The proposed study is to explore novel strategies to prolong disease control of cancer targeted therapy.
Oncogenic KRAS (KRAS*) is the key driver of pancreatic cancer, and pharmaceutical inhibition of KRAS using
chemical and other approaches is extensively developed in recent years. Utilizing a doxycycline inducible
KRASG12D mouse model with conditional p53 knockout in pancreas (iKPC), our previous publication indicates
that 70% PDAC tumors relapsed 0.5-1 year after KRAS* depletion. I identified that the crosstalk between tumor
cells and tumor associated macrophages (TAMs) promotes KRAS* depletion resistance in PDAC. My
unpublished data shows that forced expression of HDAC5 in iKPC cells leads to upregulation of Ccl2 and Ccl7
and recruitment of TAMs. S100A8+ TAMs express abundant TGFβ that enables KRAS*-independent tumor
growth. I hypothesize that the HDAC5-TAMs-TGFβ axis may serve as a general mechanism for therapy
resistance after KRAS* depletion in PDAC. In this proposal, I will evaluate the therapeutic potential of targeting
HDAC5, TAMs and TGFβ pathway in several human and mouse PDAC models by loss-of-function study.
Specifically, In Aim 1, I will determine the essentiality of HDAC5 in KRAS* bypass, and the regulation of TAM
recruitment by endogenous HDAC5. In Aim 2, I will utilize multi-dimensional analysis to illustrate the phenotypic
dynamics and heterogeneity of TAMs after KRAS* depletion, and demonstrate the essentiality of TAMs for
tumors to bypass KRAS* dependency. In Aim 3, I will utilize SMAD4 deficient models to access the essentiality
of TGFβ/SMAD4 pathway activation in KRAS* bypass, and delineate the molecular mechanisms of TGFβ-driven
KRAS* bypass. The proposed research program will help me to launch an independent faculty position in an
academic/medical research institution. Meanwhile, I will keep expanding my research skills in bioinformatics,
immunology, epigenetics and translational studies. In terms of my career development, I will devote to improve
my skills on managing lab, mentoring postdocs and students, scientific writing and presentation, and seeking for
collaborations, among others. MD Anderson Cancer Center and Dr. Ronald DePinho’s laboratory provide an
excellent environment for me to achieve these goals. I have also formed an extraordinary advisory committee
composed of Drs. Giulio Draetta, Raghu Kalluri, and Anirban Maitra. They will not only provide me technical
support for my proposed study, but also assist me to seek a faculty position and succeed as an independent
investigator. With the help of K22 award, I will have a good start to achieve my long-term goals, which are to
continue basic and translational studies in pancreatic cancer as a lab head, including but not limited to targeted
therapy resistance, and to contribute to developing novel cancer therapies with other scientists, physicians and
pharmaceutical companies as a team player.

Public health relevance
Project Narrative Tumor associated macrophages (TAMs) play an important role in tumor progression, metastasis, immune suppression and therapy resistance, but their function in oncogenic KRAS inhibition resistance is largely unknown. Preliminary study suggests that, forced expression of HDAC5 in pancreatic cancer cells promotes active recruitment of TAMs, which provide TGFβ to support oncogenic KRAS independent tumor growth. This proposal aims to investigate the necessity of tumor-TAMs crosstalk in the bypass of KRAS dependency and explore the therapeutic potentials by co-targeting KRAS and HDAC5-TAM-TGFβ axis in pancreatic cancer.